Precision genome surgery in autologous stem cell transplant

Retinal pigmented epithelial (RPE) disorders, including autosomal dominant retinitis pigmentosa (RP) and age- related macular degeneration, are an enormous burden and a growing public health concern, given the aging U.S. population. Autosomal dominant (ad) conditions emerge from mutations that allow expression of a defective protein and are generally not amenable to current “gene addition” therapies in humans, as they require precise repair to remove the gain-of-function mutation. The long-term goal is to identify ways to use patient stem cells as a tissue source for regenerative medicine (RM). The objective of this application is to determine whether autologous induced pluripotent stem (iPS) cell transplantation is a RM approach or treatment of dominant disorders. The eye provides an ideal proving ground for RM therapy, as it is an organ with relative immune privilege that is both accessible and isolated, therapies for the eye are generally neither invasive nor systemic, and its optically transparency allows treatment to be monitored easily and noninvasively in living animals. The central hypothesis is that a gene-editing strategy using a novel state-of-the-art therapeutic editing approach can suppress manifestation of a dominant RPE65D477G/+ mutation in human RP. This hypothesis will be tested by pursuing three specific aims: 1) Obtain functionally recovered RPE after CRISPR repair of corresponding RPE65D477G/+ iPS cells. Gene-editing tools and methods will be optimized for CRISPR repair of the RPE65D477G/+ mutation in iPS cells. The cells will be assessed to determine whether they are able to differentiate into RPE and to confirm their genomic integrity. 2) Determine whether in vitro- repaired patient iRPE functionally integrates into the retinae of live mice by assessing inner retinal electrophysical signals and retinoid signaling. RPE grafts will be derived from either RPE65 gene-repaired or unrepaired patient iPS cells. 3) Determine whether transplanted gene-repaired iRPE is safe and nontumorigenic. Immunocompromised Rpe65rd12/Rpe65rd12; Prkdcscid/Prkdcscid mice will be subretinally injected with iRPE grafts and tested for safety, tumorigenicity and survival. The proposed research is significant, as it will advance treatment guided by the precise pathophysiology of patient-specific mutations. The proposed research is innovative because it uses a new approach to generate repaired RPE cells for transplantation, should not require immunosuppressive therapy, and make use of innovative outcome measurements. The research is expected to have an important positive impact as it represents the initial steps of a precision medicine approach directed toward developing treatments targeting dominant mutations unique to individual patients with RP, AMD, and other dominant disorders, while introducing new methods and model systems. .

Public health relevance
Project Narrative Incurable autosomal dominant retinitis pigmentosa (RP) due to dominant negative mutations in RPE65D477G/+is severely debilitating. Autologous induced pluripotent stem (iPS) cell transplantation is a patient “heal thyself” regenerative medicine strategy. Success identifying and optimizing the ideal CRISPR genome surgery best suited for autosomal dominant disorders.